INSULIN SENSITIVITY &GLUCOSE HOMEOSTASIS IN NIDDM ADDOLESCENTS

Epidemiological studies have demonstrated that black Americans have a 2-3 fold higher prevalence of type 2 diabetes as well as an earlier age of onset. This study evaluates the insulin sensitivity indices as well as the impact of family history and race on glucose homeostasis of type 2 diabetes black and white adolescent populations. Relationships between body composition variables and insulin sensitivity indices in the adolescent population in both races will be examined.